Alliance Central: A platform for sustainable development of next generation genome knowledgebases

Project Summary
The Alliance of Genome Resources (the Alliance) is a “knowledge commons” for expertly curated genomic data
and annotations provided by model organism databases (MODs) and the Gene Ontology Consortium (GOC).
Our mission is to facilitate the use of model organisms to understand human biology and disease. The Alliance
is organized as two interconnected functional units: Alliance Central and Alliance Knowledge Centers. Alliance
Central is responsible for development and maintenance of the software platform and shared modular
infrastructure and for the coordination of data harmonization activities across the Knowledge Centers. Alliance
Knowledge Centers such as the MODs and the GOC are responsible for expert curation and for submission of
data to Alliance Central using common data formats. Knowledge Centers also are responsible for organism-
specific user support activities, resources, and user access to data not yet supported by Alliance Central. This
U24 application seeks support for the activities of Alliance Central. The proposal reflects a new and
transformational approach to modernizing the MOD/GOC ecosystem, increasing the impact and utility of
essential community genome resources, and optimizing operational efficiencies for knowledgebases. The aims
build on the significant accomplishments we achieved as a consortium since we launched the Alliance in 2016,
including: a common management and governance structure, Working Groups, multiple channels for
communications among consortium members, infrastructure for coordinated software development and version
control, data sharing with the NIH Data Commons Pilot initiative, the development of a common set of orthologs,
the release of the Alliance web site and APIs, and successful development of software components that have
been adopted by both Alliance members and external resources. Our focus for Specific Aim 1 will be on
implementing a shared platform for ingesting, storing, and harmonizing data for MODs. We will continue our
long-standing commitment to data management practices that align with FAIR principles. In Specific Aim 2 we
describe our plans to implement common methods, including well-documented APIs, for access to model
organism data and annotations. The deliverables for this aim will foster widespread adoption and use of Alliance
data and resources for the development of new applications for biological discovery and translational research.
In Specific Aim 3 we describe our plans to implement a framework to support the development and deployment
of software applications, workflows, and analysis tools that use model organism data and annotations. The
enhanced functionality for comparative genomics fostered by these innovations will empower the biomedical
research community to leverage knowledge across multiple organisms for hypothesis generation and pattern
discovery. Finally, in Specific Aim 4 we describe the management and organization of the Alliance as well as
the planned activities of our centralized user support helpdesk.

Public health relevance
Project Narrative The Alliance of Genome Resources (the Alliance) is a “knowledge commons” for expertly curated model organism data and annotations generated by model organism databases (MODs) and the Gene Ontology Consortium (GOC). The mission of the Alliance is to advance the utility of diverse model organisms for investigating the genetic and genomic basis of human biology, health and disease. The primary goals of the Alliance are (1) to provide unprecedented support for comparative genomics via unified user interfaces and APIs for data types shared by the MODs, and (2) to promote sustainability and operational efficiencies by building a “knowledge commons” based on shared, modular infrastructure.